A Simple Multiplexed Platform for Self-Administered HIV and Hepatitis B Testing

Multiplexed Patient Administered Diagnostics for Hepatitis B, Hepatitis C, and HIV: HIV and viral hepatitis infections share common modes of transmission and social and structural barriers to accessing care and services among key populations. Coinfection with HIV significantly impacts the pathogenesis of HBV and HCV and is associated with reduced spontaneous clearance of HCV and HBsAg, higher rates of chronicity and occult HBV, higher HCV viral loads, rapid disease progression, and increased risk of morbidity and mortality due to cirrhosis and HCC. Integrated strategies for screening and diagnosis of HIV and viral hepatitis infections are therefore critical to an effective global health response. This contract aims to develop a novel, low-cost multiplexed analyzer capable of fully automating both molecular and immunoassay test formats using fingerstick blood samples for use by patients and untrained healthcare staff for detection of HIV-1 and HBV.